Mechanisms and Therapeutic Targeting of CD4 Down regulation in African Green Monkeys

Project Summary/Abstract
Given the success of fully-suppressive antiretroviral therapy (ART) regimens, efforts have shifted over the
past decade to strategies aimed at eradicating the body of HIV. The vast majority of these strategies tested in
vivo have relied on some form of the “shock and kill” approach. To date, all of these studies have failed to
accelerate decay of the HIV reservoir. These outcomes highlight both the long road to refinement of current
shock and kill approaches and the need to explore alternative HIV cure avenues.
An approach with significant promise in this setting relies on experimentally ablating CCR5 to render cells
resistant to HIV-1 infection. Natural hosts of SIV circumvent disease progression in spite of ongoing viremia and
have evolved to naturally regulate HIV-1/SIV entry receptors. African green monkeys (AGMs), in particular, post-
thymically down-regulate CD4 to become refractory to SIV infection, a process resulting in anecdotal instances
of AGMs evidently curing themselves of SIV. Despite the profound consequences, the molecular events
governing this process are entirely undefined. Our previous studies revealed that CD4 down-regulation is
mediated in part by DNA hypermethylation of the CD4 promoter region. In this study we will examine the overall
hypothesis that CD4 locus methylation in AGMs is the result of uniquely regulated trans-acting factors and
manipulating these trans-acting in progressive host CD4 T cells can induce CD4 instability and phenocopy the
virus-resistant qualities of AGM T cells. We identified two particular trans-acting factors uniquely regulated in
AGM T cells that lose CD4. In aim 1 we will focus on the Ten-eleven translocation protein 3 (TET3), a DNA
demethylase found to be down-regulated upon loss of CD4 in AGMs. In aim 2 we will focus on the wnt signaling
transcription factor TCF-1, which we find to be uniquely down-regulated upon AGM CD4 down-regulation. Both
aims will follow a similar workflow to causatively determine the role of these factors in CD4 regulation. By lentiviral
transduction, we will determine if over-expression of TET3 or TCF-1 rescues CD4 on the surface of AGM T cells.
We will then employ CRISPR-cas9 gene editing techniques, asking if genetic ablation of these factors in rhesus
or human cells can promote CD4 instability, and whether this leads to virus resistance by in vitro infection assays.
These aims test an overall model of CD4 gene promoter regulation based on natural host co-evolution with
SIV. The proposed experiments will extend this model to progressive hosts in the hopes of implementing a
“bulletproof” strategy to render T cells resistant to all HIV-1/SIV strains, regardless of tropism. If successful, the
proposed studies will generate data for a more comprehensive proposal aimed at in vivo studies of autologously-
transferred, virus-resistant T cells.

Public health relevance
Project Narrative African green monkeys, which are natural hosts of SIV, reduce target cell number by down-regulating CD4. Our proposed studies will examine the molecular events governing this evolved phenomenon and seek to harness this mechanism in progressive hosts to render cells resistant to SIV infection. In the long-term, this project will pave the way for in vivo transfer of virus-resistant T cells, akin to similar HIV-1 cure approaches aimed at populating the host with CCR5-deficient T cells.